UNC Chemical Biology Interface Training Program

ABSTRACT
We propose to establish a Chemistry–Biology Interface (CBI) Training Program that will enable trainees at the
University of North Carolina at Chapel Hill (UNC) to obtain the breadth of scientific training essential for
modern, mechanistically informed chemical biology. This program draws from two historically successful
programs at UNC: the Division of Chemical Biology and Medicinal Chemistry (CBMC) in the UNC Eshelman
School of Pharmacy, and the Biological and Organic Chemistry Divisions in the UNC Department of Chemistry
(College of Arts and Sciences). These two units have a strong and continuing tradition of collaboration,
common coursework, and a shared seminar series. Although UNC has a highly regarded scientific tradition,
there is no chemistry-oriented NIH training program on the UNC campus. The proposed program will bring
together 25 established researchers who encompass the breadth of chemical biology, ranging from analytical
bioanalysis to protein structure/function to medicinal chemistry/drug design. In addition, three promising junior
faculty members will join the program as “mentored mentors”, working closely with senior colleagues as they
continue to establish their programs. The program leaders, one from CBMC and one from the Department of
Chemistry, are accomplished senior faculty with mentoring and administrative experience; they will provide
program guidance with input from an internal steering committee and a distinguished group of external
advisors. Students will be recruited from the two primary units and from a UNC umbrella biological/biomedical
sciences program that has shown remarkable success in recruiting outstanding and diverse graduate students
to the campus. The training program includes (1) common coursework that establishes the basis for research
at the chemistry–biology interface, including responsible conduct of research and rigor/reproducibility training,
(2) biweekly meetings that alternate between a journal club and a smaller discussion group focused on
individual learning and professional development, (3) an program retreat that will be held before the fall
semester, providing orientation and early formal training in rigor and reproducibility, and (4) a trainee-organized
symposium that will become a major annual event at UNC. Work at the chemistry–biology interface has
become increasingly relevant as our understanding of biology has required more molecular insights.
Accordingly, the activities of the proposed program will capitalize on the diverse expertise in CBMC and
Chemistry, and the extensive educational and research resources that are available at this internationally
recognized institution. This program will provide trainees with a superior education from the perspective of
depth and breadth, and develop well-trained PhD scholars at the interface of chemistry and biology who will
play a critical role in the biomedical sciences across academia and industry.

Public health relevance
NARRATIVE As our understanding of how molecular structure affects biological processes increases, interest in performing research at the boundary of chemistry and biology has increased. The range of learning at this interface is large and poses great challenges for educating emerging biomedical scientists who incorporate chemistry into their work. We seek to establish a comprehensive training program that will empower young people beginning their careers in this field at the University of North Carolina at Chapel Hill.